Role of mitochondria in SLE and its cardiovascular complications

Summary: Upon cellular death, cells release damaged mitochondria, contributing to local
inflammation. The overall aims of the present study are to investigate how mitochondria are
cleared to avoid evoking an aberrant immune response, and to determine if autoantibodies
targeting mitochondrial proteins have clinical utility in assessing development of thrombosis in
patients with systemic lupus erythematosus (SLE). The premise of the study is that SLE patients
have impaired clearance of mitochondria, promoting development of mitochondrial antibodies,
inflammation and organ damage, including thrombosis. To investigate this we have three main
aims. The first aim investigates how mitochondrial extrusion promotes autoimmunity towards
mitochondrial protein antigens, attempting to define the exact target of novel main mitochondrial
autoantibody, AMA-17, the processes involved in exposing the autoantigen in vitro, as well as
potential therapeutic targets, e.g. mitochondrial ROS, involved in generating AMA-17 in vivo.
The second aim investigates how anti-mitochondrial antibodies partake in thrombosis
development. Using a large longitudinal SLE cohort (n=500), followed over 10 years, we will
determine the capacity of AMA-17 to associate with and/or predict development of venous
thrombosis. Affinity-purified AMA-17 antibodies will be tested for platelet activation and
thrombus formation in vitro using flow cytometry, aggregometry and a cutting-edge model of
engineered microvessels, as well as in vivo using a novel model of antibody-mediated venous
thrombosis developed by Dr. Knight. Finally, in Aim 3, we will investigate underlying
mechanisms involved in clearance of mitochondria, with an emphasis on the role of complement
C1q and C3 to facilitate silent clearance. These studies will be done both in vitro using select
isolated complement components, as well as in vivo using unique C1q and C3 deficient mice.
Outcome measures include phagocytosis, cytokine production, and NET formation.
Downstream signaling pathways involved in mitochondrial-mediated inflammation will be
identified using mass spectrometry-based phosphoproteomics. In all, our study aims at
identifying fundamental mechanisms regulating inflammation, thrombosis and autoimmunity in
the context of human disease, with an emphasis on the role of the complement system in silent
removal of mitochondria. We expect the proposed research to provide novel therapeutic targets
disrupting the inflammatory and immunogenic properties of mitochondria, applicable for many
diseases, including SLE and rheumatoid arthritis, as well as identify prognostic mitochondrial-
derived biomarkers enabling early and preventive treatment of venous thrombosis.

Public health relevance
Project narrative: Dying cells release several toxic components, including their bacterial-resembling power plants, mitochondria, a process known to promote inflammation and autoimmunity. However, we still do not fully understand how the released mitochondria contribute to inflammation and disease. In the current proposal, we aim to study how mitochondria are recognized and removed by our immune cells to avoid unwarranted inflammation, organ damage, and autoimmunity, with the ambition to identify novel pathways and biomarkers that could be targeted and monitored in mitochondrial-mediated diseases, in particular lupus.